Preventing Hypertension and Sympathetic Overactivation by Targeting Phosphate

Project Summary Inorganic phosphates (Pi) are widely used in the food industry as preservatives. High Phosphate (Pi) intake is a well-recognized contributor to vascular calcification and cardiovascular mortality in patients with renal failure. More recently, a high Pi diet was shown to trigger BP elevation even in rodents with normal kidneys. Mechanisms underlying detrimental effects of high Pi diet are complex and largely unknown but our recent study in rats have identified novel mechanisms mediating Pi-induced hypertension (HTN) and left ventricular hypertrophy via overactivation of the sympathetic nervous system. Our data also suggest that animals fed a high Pi but constant sodium intake have an elevated cerebrospinal fluid content of fibroblast growth factor 23 (FGF23, a key hormone in Pi homeostasis), and reduced expression within the central nervous system (CNS) of Klotho (a key protein in Pi homeostasis). Klotho has also been shown to increase nitric oxide (NO) production in the vasculature. In the CNS, it has been established that NO produced by the neuronal form of nitric oxide synthase (nNOS) plays a major inhibitory role on central sympathetic outflow. Klotho expression was shown to increase after regular exercise in mice and humans. However, the role of dietary Pi, Klotho, and FGF23 in the neural control of blood pressure (BP) has not been investigated. Thus, we propose parallel translational studies in normal rats and prehypertensive humans (BP 120-129/80-84 mmHg) to systematically investigate the influence of dietary Pi on sympathetic nervous system and BP regulation. The proposed studies are innovative in that they maintain the potential to shift current clinical practice paradigms by identifying phosphate as a key modifiable risk factor for the prevention and treatment of hypertension. The ultimate results of our work could lead to more effective strategy in reducing the global burden of hypertension and target organ complications. We envision this work advancing the field in several important ways: (1) translating work from rodent models to human hypertension, using of the state-of-the-art techniques of microneurography; (2) examining the role of dietary phosphate in neural control of BP both at rest and during exercise, which has not been previously addressed; (3) demonstrating the role of inorganic phosphate in regulating BP via alteration in the concentration of soluble klotho or FGF23 in the central nervous system, (4). Establishing a new role of exercise training in preventing phosphate-induced sympathetic overactivation and hypertension, and (5). Establishing a novel role of FGF receptor in the central nervous system in mediating phosphate- induced hypertension.

Public health relevance
Project Narrative Inorganic phosphates (Pi) are widely used in the food industry as preservatives. High Phosphate (Pi) intake is a well-recognized contributor to vascular calcification and cardiovascular mortality in patients with renal failure. More recently, a high Pi diet was shown to trigger BP elevation even in rodents with normal kidneys. The current proposal aims to examine the mechanisms of Pi-induced hypertension and its relevance in humans.